Administrative Core

The primary objective of the Administrative (Admin) Shared Resource Core (SRC) is to provide the foundation
for integration, coordination, and management of all components of AMPLIFI, (i.e., the three research projects
and three additional SRCs). The Admin SRC also is responsible for all budgetary and regulatory activities
(processing incentives, IRB clearance and amendments, coordinating DSMB oversight, etc.) and work required
for all program components. In addition, the Admin SRC team will arrange for meetings amongst the
investigators, and perform the majority of supply shipment, as well as file progress reports. As part of the
supplies, the Admin SRC will provide computer tablets and internet service coverage to any study participants
who do have current internet access via computers, smartphones or other devices; the IT specialist within this
SRC also will provide training and guidance for participants who require this support in order to participate fully
in the 3 projects. This SRC also will maintain the study toll-free number and will track, triage, and report any
adverse events, and also will coordinate annual DSMB reviews.
The Specific Aims are to: (1) Integrate overarching program aims with project-specific outcomes; (2)
Coordinate the activities of the research projects and resource cores to ensure that the AMPLIFI goals and
outcomes are achieved; and (3) Lead effective management and scientific integration of AMPLIFI components.
Using a comprehensive approach, we will leverage our shared resource cores and infrastructure to accomplish
the following: 1) identify how best to reach underserved older, rural, and minority cancer survivors; 2) engage
survivors in exercising more and making healthier food choices that result in improved diet quality and weight
control; 3) determine whether behavioral interventions in specific domains should be presented sequentially or
simultaneously in this population; and assess the cost-effectiveness of the adapted health behavior
interventions. Thus, the proposed work is integrated and synergistic across multiple dimensions to leverage
research infrastructure, collaborative relationships, and the investigators' expertise to achieve greater
outcomes compared to the sum of the differential parts.

Public health relevance
PROJECT NARRATIVE The goals of the AMPLIFI Administrative Shared Resource Core (SRC) are to: (1) integrate the overarching program aims with project-specific outcomes; (b) coordinate the activities of the three research projects and three additional SRCs (i.e., ADI, AA, RR) to ensure that the Project goals and outcomes are achieved; and (c) lead effective management and scientific integration of AMPLIFI components. By achieving its aims of program implementation and management, the Administrative SRC will enhance efficiency and assure that synergies are realized across projects so that scientific contributions are optimized - contributions that will significantly advance survivorship research and, ultimately improve the well-being of millions of cancer survivors, including older, rural, and minority survivors who are traditionally underserved.